Toward Accurate Cardiovascular Disease Prediction in Hispanics/Latinos: Modeling Risk and Resilience Factors

PROJECT SUMMARY/ABSTRACT
Existing heart disease and stroke prediction models (e.g., Framingham) tend to overestimate risk for
Hispanics/Latinxs (H/L)s. This inaccuracy has significant economic and public health impacts associated with
inaccurate surveillance, intervention targeting, and medical management. Model inaccuracies likely stem from
pervasive underrepresentation of H/Ls in model development and validation efforts. Consequently, traditional
risk factors for cardiovascular disease (CVD) may be specific to the populations upon whom they were derived,
and not generalizable to H/Ls. In addition, there may be unique disease determinants for H/Ls that remain
untested or unincorporated leading to error in prediction. Importantly, resilience factors such as culturally-
moderated social capital may be critical to understanding risk in this population. Addressing these gaps will
lead to better understanding of CVD risk with corresponding implications for targeted intervention strategies.
This K99/R00 MOSAIC proposal will use secondary data to inform current 10-year CVD risk models using
theory and data-driven methods to increase CVD prediction model accuracy in H/Ls. The proposed training
plan establishes a solid foundation for a career investigating H/L CVD risk and resilience factors. The training
plan leverages substantial resources at The University of Arizona and a mentoring team of senior content
experts. The candidate will gain the following, 1) expertise in H/L CVD disparities, 2) advanced knowledge in
CVD epidemiology, risk, and etiology and pathophysiology of atherosclerotic disease, 3) applied machine
learning, cross-validation, and selection of risk prediction models, and 4) cultural factors and social capital
influencing H/L CVD. The research proposal has three aims focused on evaluating and informing existing 10-
year CVD prediction in H/Ls. Using secondary data from the Hispanic Community Health Study/Study of
Latinos (HCHS/SOL), the candidate will (Aim 1 – K99) evaluate the prediction accuracy of current 10-year
CVD risk models using a large H/L sample with significant representation of diverse H/Ls (HCHS/SOL). (Aim 2
– R00) the candidate will use available data to identify a group of target risk factors that improve risk prediction
in H/Ls. (Aim 3 – R00) the candidate will test whether adding a social resilience component to CVD risk
models will improve their prediction accuracy for this group. Machine learning will be used to identify valid
predictors of 10-year CVD in Latinos. The social resilience component will capture the multi-dimensionality of
social environments (e.g. spouse, family, neighborhood) using data reduction methods. The proposed research
proposal adopts a holistic view of cardiovascular health to elucidate both risk and resilience factors in this
growing ethnic group.

Public health relevance
PROJECT NARRATIVE Existing heart disease and stroke prediction models (e.g., Framingham) tend to overestimate risk for Hispanics/Latinxs (H/L)s resulting in significant economic and public health impacts. There may be unique disease determinants for H/Ls that remain untested or unincorporated, which may deviate from traditional conceptualizations of cardiovascular disease (CVD) risk such as the role of culturally-moderated social capital. This project will inform prediction models and improve accuracy for H/Ls by identifying CVD risk and resilience factors using theory and data-driven methods to address knowledge gaps.